Cell-derived therapies for corneal nerve repair: Structural and functional mechanisms

PROJECT SUMMARY
Injured corneal nerves can regenerate but in general, the resulting nerve repair is incomplete or may take
years to recover their original density and patterning. While several growth factors can enhance the
recovery of damaged corneal nerves and one of them has been clinically approved to treat corneal injuries
(nerve growth factor), patients still complain about discomfort, dryness, and pain. These observations
indicate that more complete anatomical and sensory regeneration of injured nerves may need to occur for
patients to recover. Most likely the type/site/time of nerve injury affects the anatomical, molecular, and
functional regeneration of corneal nerves. Therefore, the administration of clinically validated factors that
enhance nerve regeneration, not only accelerates the rate of healing but also induces differential effects
on functional nerve sensation. Since regeneration of corneal nerves requires multiple wound healing
processes, the use of single agents may not be the best therapeutic approach, and combination of factors
with similar or complementary roles may be necessary to accomplish repair at the morphological and
functional levels.
In this proposal, we hypothesize that secreted extracellular vesicles (including exosomes)
derived from different sources differentially regulate the anatomical, molecular, and functional
aspects of regenerating corneal nerves. To identify these changes, we proposed the following: Aim
1 will characterize the ability of extracellular vesicles (EVs) derived from mesenchymal stem cells
(MSCs) to promote the anatomic and molecular regeneration of corneal nerves following mechanical
and chemical injury. Aim 2 will evaluate the functional and behavior recovery of corneal nerves following
administration of EVs. Aim 3 will elucidate the bioactive components of the extracellular vesicle’s cargo,
which can lead to new therapeutic approaches for complete corneal nerve repair.

Public health relevance
PROJECT NARRATIVE Cornea nerves can be damaged by trauma, surgery, infection or diabetes. In this proposal, we will investigate the regenerative potential and functional consequences of adding extracellular vesicles derived from mesenchymal stem cells to damaged corneal nerves. We expect to elucidate basic mechanisms that may lead to new clinical therapies for pathologies that affect the corneal nerves.